PLASMA TESTOSTERONE CONCENTRATIONS ON GH SECRETION AND BASAL METABOLIC RATE

This research examines the effects of variations in serum testosterone levels on GH secretion and basal metabolic rate in normal men. Subjects will be studied 3 times, in random order, under conditions of low, normal, and elevated testosterone. Both stimulated and non-stimulated GH secretion, BMR, and lipids will be measured during each admission.